Administrative Core

PROJECT SUMMARY: ADMINISTRATIVE CORE
The overarching goal of the Administrative Core is to ensure smooth functioning of the primary projects, pilot
grants, research cores, and CNAP programs. We have recruited individuals with strong expertise in research
project development, grant writing and grant management, research mentoring, and research administration to
ensure that the overarching goals are met. The four aims of the Administrative Core are: (1) To promote R01-
level award success for CNAP project and pilot grant leaders. The Administrative Core will implement the
mentoring program to help achieve this aim. We have recruited two expert mentors for each of the three
projects and will recruit one or more mentors for each pilot grant and future replacement projects with specific
expertise in research areas relevant to each project. The mentors are nationally known researchers with
considerable mentoring experience. The mentors bring their outstanding expertise to ensure that the projects
develop high-impact research programs with potential for R01-level award success. The Administrative Core
will also implement a new grant writing program to ensure that investigators submit high-quality grant
proposals. (2) To continue to develop a critical mass of researchers in cognitive/neural plasticity through
recruitment of new CNAP members. The Administrative Core will facilitate hiring of new faculty, recruit new
pilot grants and replacement projects, and support of the expansion of the research cores. (3) To further
improve research infrastructure through expanding three multi-user core laboratory facilities. The Behavioral
Neuroscience Core, the Cognitive Neuroscience Core, and the Neuroinformatics Core will support the primary
projects and pilot grants as well as supporting collaborative research through the Scientific Exchange Network
(SEN). (4) To enhance the research capabilities of CNAP center members through strengthening the SEN. The
SEN will stimulate the expansion of CNAP research programs into new areas through scientific skills training
programs, use of other core facilities, and development of new research collaborations. The SEN will play an
important role in supporting primary projects and pilot grants, and the further development of the research
cores. The Administrative Core will ensure achievement of the overall CNAP aims, which will result in the
further development of a strong COBRE center of research excellence that will significantly advance our
understanding of cognitive and neural plasticity to promote healthy functioning.

Public health relevance
PROJECT NARRATIVE: ADMINISTRATIVE CORE Not applicable. See Overall plan.